BETA 2 RECEPTOR CONTROL OF CATECHOLAMINE RELEASE AND VASODILATION

Define the relevance of the change of the demonstrated on leukocyte beta receptors to other tissues including the heart and vasculature. Examine the factors regulating presynaptic beta 2 receptor sensitivity in health and disease and determine the relationship between changes in presynaptic beta 2 receptor sensitivity.